Flow Cytometry Shared Resource

PROJECT SUMMARY: FLOW CYTOMETRY SHARED RESOURCE
The Sylvester Comprehensive Cancer Center (Sylvester) Flow Cytometry Shared Resource (FCSR) offers
comprehensive, readily accessible, cost-effective, state-of-the-art analytical flow cytometry and cell sorting
services that are critical to the success of a wide range of cancer research, including complex
immunophenotyping, DNA content and cell cycle analysis, cell signaling and pathway activation analysis, and
measurement of proliferation and apoptosis. The aims of the FCSR are to 1) provide state-of-the-art
instrumentation and high-level expertise for fluorescence-activated cell sorting (FACS), standard and spectral
flow cytometry, and mass cytometry and imaging mass cytometry (IMC); 2) develop, optimize and offer
existing and emerging cytometric methods; and 3) provide training in all aspects of cytometry. The facility has
nine major research instruments (four cell analyzers, three cell sorters, and two mass cytometry platforms)
that facilitate studies of normal and cancer cells. The FCSR works closely with other Shared Resources to
support genomics and spatial multiomics research. FCSR cell sorters can sort based on up to 17
fluorescence markers, into bulk tubes or multi-well plates for single-cell cloning under BSL-2 conditions. The
FCSR also offers expertise and access to spectral cytometric analysis of up to 40 fluorescent parameters for
both cell surface and intracellular antigen detection in complex mixtures of cancer cells and adjacent normal
tissue. Moreover, the FCSR provides CyTOF mass cytometry and IMC services (with instruments funded by a
competitive grant award from the State of Florida), with the capability of multiplexing up to 50 markers
simultaneously in single-cell suspensions or in tissue sections at sub-cellular resolution for spatial analysis of
the tumor microenvironment. In alignment with the 2019-2023 Sylvester Strategic Plan, Sylvester significantly
strengthened the FCSR during the current reporting period (6/1/2018-5/31/2023) by investing in equipment
(adding five major research instruments) and personnel (including a new Director). FCSR staff perform mass
cytometry and cell sorting, assist with spectral and standard flow analysis, and regularly perform maintenance
and QA/QC assessment on all instruments. They also provide training on all aspects of cytometry
experiments, including experimental and panel design, hands-on training for analyzer instruments, self-
operated sorting, data acquisition, and data analysis. During the reporting period, the FCSR supported 84
Sylvester members who comprised 84% of total usage by revenue, reflecting the critical importance of FCSR
services to members. The FCSR supported 73 publications (48% were in high-impact journals (JIF≥10)) and
facilitated 48 cancer-related grants awarded to members, including 14 NCI awards. Future plans include
implementing technologies to expand multiomics support with spatial genomics service; improving cell sorting
capabilities; and enhancing capture of the components of heterogenous cell populations. In 2022, the FCSR
was designated a Center of Excellence by the International Society for the Advancement of Cytometry.